MICROFABRICATED INSTRUMENTATION TO MEASURE SPHINGOLIPID SIGNALING IN HUMAN ACUTE MYELOID LEUKEMIA

ABSTRACT Abstract remains unchanged and is not provided under PA-18-590

Public health relevance
PROJECT NARRATI VE Project narrative is unchanged and is not provided under PA-18-590